REGULATION OF PHYSIOLOGICAL FUNCTIONS DURING AGING--ASSESSMENT OF PRIMATE

This project is attempting to determine whether caloric modification of the diets of Rhesus and squirrel monkeys can affect aging rate as assessed by various physiological, biochemical and behavioral indices.